TDP-43 acetylation as a pathogenic modification in ALS & related proteinopathies

7.??Project?Summary/Abstract?? ? Amyotrophic? Lateral? Sclerosis? (ALS)? is? a? devastating? motor? neuron? disease? with? a? 3?5? year? survival? rate? and? no? disease?modifying? therapies.? TAR? DNA?binding? protein? of? 43kD? (TDP?43)? is? a? nuclear? RNA? and? DNA? binding? protein? that? becomes? abnormally? aggregated? in? the? brain? and? spinal? cord?of?most?ALS?patients?as?well?as?a?subset?of?dementia?patients?(frontotemporal?lobar?degeneration? with? TDP?43? pathology,? or? FTLD?TDP),? placing? ALS? and? FTLD?TDP? within? a? spectrum? of? diseases? known?as?TDP?43?proteinopathies.??Although?TDP?43?pathology?has?been?implicated?in?disease?onset? and? progression,? little? is? known? about? how? TDP?43? becomes? aggregated? leading? to? progressive? neurodegeneration.??My?long?term?goal?is?to?uncover?the?pathogenic?mechanisms?that?promote?TDP?43? aggregation,?which?will?provide?insights?for?future?therapies?against?these?debilitating?diseases.?? Post?translational? modifications? have? been? implicated? in? the? progression? of? neurodegenerative? diseases.??Using?my?background?in?acetylation?biology,?I?previously?demonstrated?that?acetylation?of?the? tau? protein? promotes? tangle? formation? in? Alzheimer s? disease? and? related? tauopathies? (Nat? Commun.? 2011~2:252).??I?have?now?demonstrated?that?TDP?43?is?subject?to?acetylation,?thus?highlighting?a?new? TDP?43? modification? that? is? potentially? linked? to? ALS? and? related? proteinopathies.? ? The? central? hypothesis? of? this? proposal? is? to? determine? whether? acetylation? of? TDP?43? promotes? aggregation? and? neurodegeneration.? To? accomplish? this? goal,? I? will? acquire? expertise? in? neuropathology? from? the? mentoring? laboratory? and? analyze? TDP?43? acetylation? in? ALS? and? FTLD?TDP? post?mortem? brain? and? spinal? cord? as? well? as? TDP?43? transgenic? mice? characterized? by? TDP?43? pathology? and? neurodegeneration.? To? directly? determine? whether? acetylated? TDP?43? promotes? disease,? primary? neuronal?cultures?and?transgenic?mice?expressing?acetylated?TDP?43?will?be?evaluated?for?pathological? hallmarks,? toxicity,? and? neurodegeneration? that? recapitulate? human? TDP?43? proteinopathies.? Having? established?the?disease?relevance?of?TDP?43?acetylation,?the?independent?phase?will?utilize?in?vitro?and? cell?based?approaches?to?investigate?the?biological?significance?of?acetylation?in?causing?impaired?TDP? 43?binding?to?target?genes?and?RNAs,?leading?to?a?TDP?43?loss?of?function.??Finally,?as?an?independent? investigator,?I?will?utilize?K99?phase?training?in?neurodegenerative?disease?to?generate?a?mouse?model? of? hyper?acetylated? TDP?43? and? determine? the? ALS? phenotype? in? both? brain? and? skeletal? muscle.?? These? innovative? studies? will? highlight? TDP?43? acetylation? as? a? critical? modification? linked? to? the? progression?of?ALS?and?related?TDP?43?proteinopathies.?

Public health relevance
8.��Project�narrative�� � Amyotrophic�Lateral�Sclerosis�(ALS)�and�frontotemporal�lobar�degeneration�(FTLD�TDP)�represent�two� major�TDP�43�proteinopathies�with�no�effective�treatment�strategies.��The�proposed�studies�will�provide� insights�into�the�underlying�mechanism�of�TDP�43�aggregation�and�highlight�acetylated�TDP�43�as�a� therapeutic�target�and�potential�biomarker�for�patients�with�ALS�and�related�TDP�43�proteinopathies.�� �